UC Davis CounterACT Center of Excellence: Developing Therapeutic Strategies for Mitigating the Chronic Neurological Consequences of Acute Organophosphate Intoxication

Project Summary – Overall
The primary objective of the new UC Davis CounterACT Center of Excellence is to identify and develop novel
therapeutic strategies that when administered as an adjunct to in-field standard of care (SOC) treatments for
acute organophosphate (OP) intoxication will mitigate the onset and/or severity of long-term, adverse
neurological consequences. The overarching hypothesis of the Center is that therapeutic strategies that
reduce inflammation in the brain, protect blood-brain barrier (BBB) function, and/or normalize neuronal
excitability will be more effective than SOC alone in improving long-term neurological outcomes. Current medical
countermeasures can reduce mortality in OP-intoxicated individuals, but they do not provide protection against
the long-term neurological sequelae associated with acute OP intoxication unless they are administered within
minutes of exposure, which is an unlikely scenario in the event of accidental, suicidal or terrorist-related
exposures. These limitations underscore the urgent need for improved medical countermeasures. The Center
consists of three Research Projects: Project 1 will evaluate novel therapeutic candidates that reduce
neuroinflammation; Project 2 will assess strategies for protecting BBB function; and Project 3 will test
pharmacologic and electrophysiologic strategies for normalizing neuronal excitability. Three Scientific Cores
support the Projects: the Analytical and Medicinal Chemistry Core will support biomarker detection, medicinal
chemistry, formulation and PK studies; the Neuroimaging Core will provide preclinical in vivo and high-content
imaging; and the Statistics Core will support experimental design and data analyses. A Research Education
Core will provide training in countermeasure research, and an Administrative Core will function as the Center’s
hub and administer the Emerging Science and Scientists Pilot Project Program. The Center will use two
preclinical models of acute OP intoxication: the rat model of acute intoxication with diisopropylfluorophosphate
(DFP) and the rat model of acute soman intoxication, which recapitulate the acute (cholinergic crisis and status
epilepticus) and chronic (progressive neuropathology, spontaneous recurrent seizures (SRS) and cognitive
impairment) effects observed in humans acutely intoxicated with OPs. Our goals in this 1st project period are to:
(1) Identify novel therapeutic targets based on mechanistic studies of the pathogenesis of chronic, adverse
neurological effects of acute OP intoxication. (2) Develop therapeutic candidates that when given singly or in
combination as adjunct therapy to SOC prevent or mitigate chronic neurotoxicity. Therapeutic candidates include
novel small molecule inhibitors of soluble epoxide hydrolase (sEH), plasminogen activator inhibitor-1 (PAI-1), or
calpain; KCA channel activators; and FDA-approved therapies (IL-1β blocker, ion channel modulators and deep
brain stimulation). (3) Identify biomarkers (blood-borne molecules, as well as brain electrophysiology,
neuroimaging and behavioral indices) that can be translated to clinical use for predicting the development of
SRS and cognitive dysfunction in exposed individuals.

Public health relevance
Project Narrative – Overall Acute intoxication with organophosphate (OP) pesticides or nerve agents can trigger seizures that rapidly progress to life-threatening status epilepticus, and survivors often experience significant long-term morbidity, including progressive brain injury, spontaneous recurrent seizures, and cognitive impairment. Current medical countermeasures for acute OP intoxication can prevent death, but are unable to fully protect against the long- term adverse neurological consequences unless administered within minutes of exposure, which is an unlikely scenario in the event of accidental, suicidal or terrorist-related exposures. The UC Davis CounterACT Center of Excellence seeks to identify and develop novel disease-modifying therapeutic strategies that can be administered in hours to months after exposure to delay the onset and/or reduce the severity of chronic neurotoxic effects.